REAGENTS FOR ORGANIC SYNTHESIS BASED ON TRANSITION METAL

The basic objectives of this proposal are to develop new reagents for organic synthesis which provide new approaches to natural product and drug synthesis. Reagents will be derived from titanium-methylene and ketene chemistry that is uder development in our laboratory. These reagents provide new pathways for the construction of carbon-carbon double bonds, the quaternarization of ketone-carbon centers and new paths to metallacene mediated aldol chemistry.